Einstein's Nathan Shock Center of Excellence in Basic Biology of Aging

Summary
The Proteostasis of Aging Core (PAC) is a resource for investigators interested in the study of changes in
proteostasis in aging and age-related disorders at the Einstein-Nathan Shock Center (E-NSC) and elsewhere by
providing state-of-the-art methodology for the study of changes in components of the proteostasis network. The
PAC has provided 917 services for 105 groups worldwide, contributed to 42 publications, generated data for 23
grant applications and catalyzed numerous collaborative projects. The Specific Aims of this Core are to: 1)
perform comprehensive and highly specialized assays for the study of autophagy and other proteostasis
components; 2) distribute validated reagents, samples and protocols for the study of proteostasis; 3) provide
advice on experimental design, techniques, procedures and data interpretation for proteostasis analysis and for
development of proteostasis targeting interventions; 4) develop and adapt state-of-the-art methodology for the
study of proteostasis; 5) contribute to training of aging investigators in methods and procedures for the study of
proteostasis, and 5) become a resource for information in proteostasis through integration with the NSC
coordinating center and with information from other NSC cores.
The activities of the Core are organized into four groups: 1) Service: comprehensive battery of assays to
study protein turnover, activities of the different autophagic pathways and proteasome and lysosomal function in
general. 2) Resources: provides validated reagents, samples and protocols for the study of proteostasis in
aging. 3) Consultation and training: includes meetings with PAC experts for experimental planning, data
interpretation and drug design, and hands-on training sessions with the technician. 4) Innovation: explores,
tests and implements procedures for the study of protein homeostasis with emphasis on autophagic pathways.
Personnel: 1) Director (Dr. Cuervo) supervises all activities of the Core, offers advice, assists with results
interpretation and communicates with the Advisory Committee to establish prioritization/ workflow patterns. 2)
Two experts provide advice on proteostasis, perform morphometric analysis and supervises implementation of
new procedures and provide advice on drug design, experimental design of interventions and interpretation of
results. 3) The PAC technician performs assays offered as a service, contributes to training and assures
maintenance of equipment and stocks. Relevance: Unique services and continuous actualization of technology
and resources offered by the Core allow for comprehensive quantitative analysis of changes in proteostasis in
aging, age-related disorders and the of the effect of different interventions. Centralization of procedures and
resources optimizes cost efficiency and guarantees standardization, validation and tight quality control.